Antibody biomarker discovery for current and recent asymptomatic malaria exposure

ABSTRACT The Abstract in the parent application submitted on 12/05/2019, and as amended and submitted on 8/4/2020 to Dr. John Pesce remain the same with this supplement application. Per PAR-20- 272 and NOT-OD-21-074, we are submitting a request for supplemental funds of $2500/year for the purpose of childcare.

Public health relevance
PROJECT NARRATIVE/RELEVANCE The Project Narrative/Relevance in the parent application submitted on 12/05/2019, and as amended and submitted on 8/4/2020 to Dr. John Pesce remain the same with this supplement application. Per PAR-20-272 and NOT-OD-21-074, we are submitting a request for supplemental funds of $2500/year for the purpose of childcare.